Imaging of brain oxygen extraction fraction in vascular contributions to dementia

Imaging of brain oxygen extraction fraction in vascular contributions to
dementia
Vascular pathology is increasingly recognized as a major contributor to cognitive impairment and
dementia, and arises from many pathophysiological mechanisms including endothelial damage of
cerebral vessels, hypoxia, and blood-brain barrier breakdown. Vascular abnormalities have been
identified as white matter hyperintensities (WMHs) on structural magnetic resonance imaging (MRI)
scans, but the heterogeneity of and mechanisms underlying WMH evolution remain unclear. This lack of
fundamental understanding of WMHs to predict cognitive impact is in large part due to limited imaging
technologies to directly assess brain pathophysiology in clinical settings.
In this project, we develop and optimize a new MRI technique to assess a critical parameter of
brain vascular health, oxygen extraction fraction (OEF), in elderly patients with WMHs indicating the
presence of cerebrovascular disease. In ischemic brain disorders, vulnerable tissue around an infarct
compensates for reduced blood flow by increasing OEF, such that pathologically high OEF is an
important indicator of a “penumbra” of at-risk tissue. However, MRI tools to measure OEF are limited
by low signal-to-noise ratio and biological confounds on the MRI signal, and have not been fully tested in
elderly patients at risk of cognitive impairment.
We aim to address these limitations by using a novel, clinically feasible MRI method to map OEF
in brain tissues. This quantitative BOLD (blood oxygenation level dependent) technique adopts a unique
MRI acquisition in synergy with a biophysical model of microvessels in each voxel to quantify OEF. Using
quantitative BOLD MRI in patients with vascular contributions to dementia (VCID), we will 1) characterize
OEF abnormalities in WMHs and surrounding penumbra for different brain locations and their relationship
to cognition; (2) associate longitudinal OEF changes with microvascular MRI markers of white matter
injury to establish an ischemic pathophysiological mechanism of WMH evolution; and (3) test the
hypothesis that OEF changes in white matter have long-range effects on functional connectivity within
brain networks that support episodic memory and executive function.
Successful completion of this project will provide critical biological knowledge about oxygenation
in WMHs and link multiple vascular biomarkers in a mechanism for WMH progression over time. The
novel OEF MRI approach also shifts the paradigm in imaging of VCID toward quantitative, physiologically-
specific measures of vascular risk. Ultimately, non-invasive OEF imaging may detect early microvascular
changes that drive neuronal injury in cognitive impairment and dementia, and serve future longitudinal
studies of interventions to prevent cognitive decline due to vascular disease.

Public health relevance
Project Narrative The proposed research aims to translate innovative magnetic resonance imaging (MRI) techniques to image brain oxygen extraction fraction in patients with vascular contributions in dementia, and understand its mechanistic relationship to ischemic injury in white matter hyperintensities. The technology developed and biological knowledge gained from the project will guide new imaging paradigms to measure brain pathophysiology that leads to cognitive impairment, and improve early vascular interventions in many neurodegenerative disorders.